CC16 in childhood and resilience to early airflow limitation in adult life

PROJECT SUMMARY/ABSTRACT
Up to 50% of cases of chronic obstructive pulmonary disease (COPD) develop the disease through a lung
function trajectory characterized by an impaired lung function growth in childhood, without necessarily
experiencing a faster decline in adult life. This “low flier” trajectory is associated with early low-grade systemic
inflammation and can lead to the development of COPD through an intermediate stage of “pre-COPD” in which
lung function deficits, respiratory symptoms, and small airway abnormalities are present and identify at-risk
individuals years before the disease is fully manifest. However, at present the factors that confer resilience to
the low flier trajectory and may, in turn, modify its sequelae on pre-COPD remain unknown. Here, we propose
that Club cell secretory protein (CC16), a pneumoprotein with critical anti-inflammatory properties, plays a
key role in protecting from the risk of early airflow limitation and other pre-COPD phenotypes linked to
impaired lung function growth in childhood. Although it is mainly produced by club cells and other non-
ciliated airway epithelial cells, CC16 can be readily measured in circulation and work completed during the
previous funding period has demonstrated that this molecule is likely to exert direct protective effects against
airway obstruction partly through anti-inflammatory properties by reducing adhesion of activated leukocytes to
endothelial cells and, in turn, preventing their lung infiltration.
In this renewal application, we intend to extend these tantalizing findings by establishing the role of circulating
CC16 in childhood as a resilience factor against early airflow limitation and pre-COPD phenotypes in young
adult life. In epidemiological and experimental studies, we will also evaluate whether these CC16 effects
counteract those induced by early systemic inflammation (assessed by an inflammatory score of 5 proteins that
we have recently linked to low lung function growth). To accomplish these goals, we will expand our CC16 Epi
Consortium to include eight international birth cohorts and establish one of the largest respiratory
epidemiological consortia to date.
Aim 1 - To determine whether deficits in circulating CC16 in childhood predict the presence of airflow limitation
and other pre-COPD phenotypes in young adult life in a large international consortium of birth cohorts.
Aim 2 - To determine whether low circulating CC16 and systemic inflammation in childhood have combined
effects on risk for pre-COPD phenotypes by young adult life.
Aim 3 - To determine whether leukocytes from low fliers with early systemic inflammation have increased
propensity to adhere to the endothelium ex vivo, and whether their adhesion to endothelial cells can be
reduced with recombinant CC16 (rCC16).
The proposed work will shed new light on the role of CC16 in resilience against pre-COPD and may pave the
way to novel CC16-centered strategies to prevent and/or mitigate the long-term sequelae of early COPD.

Public health relevance
NARRATIVE Up to 50% of cases of chronic obstructive pulmonary disease (COPD, a disease characterized by persistent airflow limitation) develop the disease because of low lung function growth during childhood. Yet, at present the factors that may confer resilience to this low lung function trajectory remain unknown. In this project, we will evaluate (1) whether Club cell secretory protein (CC16), a protein that is produced mainly in the lungs but can be measured in blood, confers resilience to the risk of early airflow limitation in adult life that is linked to low lung function growth in childhood, and (2) whether these effects are related to the anti-inflammatory properties of CC16.